A Rugged, Reliable, Portable, Safe, and Simple Naloxone HCl Auto-Injector forLife-Saving Treatment of Opioid Overdose

Project Abstract
136 people die each day from opioid overdose in the US. Naloxone has significantly decreased
opioid mortality as a first line life-saving measure, and often it is being administered by
untrained medical personnel under situations of extreme stress—which studies show leads to
accidents, missed doses and tragic consequences. Pirouette has designed a novel, low-cost,
and intuitive auto-injector called REZQGO that anyone could use to deliver lifesaving Naloxone
safely and quickly during an opioid overdose; this Phase I project supplement will assist
Pirouette in market research, regulatory planning, pricing / reimbursement strategy, usability,
and the commercialization / GMP implementation of the REZQGO product lineup.
Pirouete Medical Inc. Conﬁden�al

Public health relevance
Project Narrative Background: From 2000 to 2019, opioid overdose deaths in the US increased by 255%; and as of 2023, 136 Americans die every day.[1] Naloxone has significantly decreased opioid mortality with increased usage as a front-line life-saving bridge to emergency help and hospitalization. Naloxone HCl Injection, USP (Naloxone) is a non-addictive opioid antagonist that can be given to any person to rapidly reverses overdose symptoms (i.e., respiratory, and central nervous system depression). Naloxone is readily available across all 50 states, often without a prescription, at relatively low cost, even subsidized in many cases through various non-profit and government entities. Community Need: The community (including those susceptible to overdose, family members, first responders, and passersby) are desperately looking for a solution that increases availability, is simple and intuitive to use, and has the needed effectiveness to save a life. I-Corp will allow for a meaningful interaction between Pirouette and that community (AIM I). Availability: When used, Naloxone reverses 93.5% of opioid overdoses. [2] However, Naloxone is not always on-hand when it is needed. Community saturation through widespread distribution and adoption could avert 21% of opioid overdose deaths.[3] The clear choice in increasing adoption of Naloxone is an auto-injector, but unfortunately, there are currently no OTC Naloxone auto-injectors (NAI) available and the single prescription NAI is only available to first responders (AIM III). Usability: A NIDA study illustrated that Naloxone is often administered by untrained bystanders under extreme stress - which studies show leads to accidents, missed doses and tragic consequences.[3] Existing solutions have usability drawbacks (e.g., failure to deliver full dose, needle stick injuries, etc.) that can lead to a general fear and anxiety around using the devices. Effectiveness: The emergence of synthetic opioids (e.g., fentanyl and carfentanyl), which comprise most of the non-regulated drug market, requires improved efficacy.[5]–[7] Intramuscular (IM) administration shows a marked improvement in efficacy (2X) over intranasal due to the absorption rate and half-life in the patient's system. IM administration also requires less frequent follow-up doses (which may also help with availability). The superiority of IM administration makes it ideal for more rural settings where the opioid epidemic is most prolific.[4] Pirouette’s Solution: Pirouette Medical is developing a novel, low-profile, disc shaped auto-injector that can be used to deliver Naloxone HCl Injection, USP intramuscularly safely and intuitively. Pirouette’s NAI, REZQGO, focuses on affordability, portability, and usability. The intuitive design allows individuals with limited or no training to easily administer an injection to themselves or others. REZQGO has controlled steps to administer a dose rapidly, while minimizing the risk of accidental injections, lacerations, and needle sticks. Pirouette’s NAI aims to reduce the stress and anxiety surrounding injections through a better device, at an affordable price. As part of the Phase I SBIR parent award, Pirouette is rigorously verifying the design and usability of non-GMP prototypes of REZQGO. Based on preliminary research, interview feedback, and FDA guidance, Pirouette is initially pursuing two dose strengths: 2mg/0.4mL and 10mg/0.4mL. The 2mg dose was chosen specifically for a Direct to OTC pathway per the FDA's Overdose Prevention Framework (Docket No. FDA-2022-N-2673). The 10mg dose was selected based on the relevant FDA Product Specific Guidance (PSG# 215457). I-Corp Benefits: Pirouette’s parent award originally proposed a 5mg dose, and we still believe there is an opportunity for a third dose strength in between the currently proposed 2mg (OTC) and 10mg (Rx) doses. Conversations with several Emergency Medical Service (EMS) personnel have confirmed this need for a more potent IM initial dose in the 4-5mg range. Pirouette intends to research product-market fit as part of the I Corps program for this subsequent user need and resulting product (AIM II). To that end, Pirouette selected a diverse team of professionals with experience in project management, emergency management, regulatory, new product introduction, and commercialization. Pirouette has submitted two Pre-IND meeting requests to the FDA, one for the 2mg dose (IND#169211), and one for the 10mg dose (IND# 169426). Pirouette anticipates the meetings to be completed by mid-January 2024. The feedback directly from the FDA will also help inform Pirouette’s research in the I-Corps program to select a third dose in the product lineup, giving users another option in their fight to save lives in the Opioid Public Health Emergency. I-Corps will assist Pirouette in market research, regulatory planning, pricing / reimbursement strategy, usability, and the commercialization / GMP implementation of the REZQGO product lineup.